Gut microbial metabolites sulfonolipids mediate high fat diet-induced intestinal inflammation

High fat diets (HFDs) alter both host inflammatory responses and gut microbial metabolites. While these
metabolites have been hypothesized to mediate host intestinal inflammation, an existing gap is how to pinpoint
the functional and responsible metabolites from an extremely complicated metabolites pool that contains numerous
unknown chemicals.
We seek to discover such functional metabolites and establish their role in modulating HFDs-induced
intestinal inflammation. In our preliminary study, we first established a mouse model that displayed HFDsinduced
intestinal inflammation. We next performed comparative metagenomic analysis of the gut microbiome
collected from aforementioned mice, leading to identification of a genus, Alistipes, which was significantly increased
during HFDs-induced inflammation. Alistipes is isolated primarily from clinical samples and shows emerging
implications to inflammation, motivating us to investigate the potential links between Alistipes metabolites and
the observed intestinal inflammation of our mouse model. Thus, we developed complementary metabolomics and
genome mining approaches: metabolomic analysis of the mice fecal and serum samples directly displayed
metabolic changes while genome mining revealed unique patterns of biosynthetic gene clusters that encode the
metabolites of interests. Indeed, the cross-validation of these two approaches led to the discovery of a class of rare
lipids, sulfonolipids (SLs) which were significantly increased in the HFDs-fed mice samples. The potential
biosynthetic genes of these SLs were also accumulated in the HFDs-fed mice samples. The pure SLs were
subsequently isolated, with the chemical structures elucidated by NMR. We then tested sulfobacin A, a major
member of the isolated SLs, and it indeed induced macrophage RAW264.7 inflammatory responses by RT-PCR
and ELISA analyses. All these preliminary data suggest that gut microbial metabolites SLs mediate HFDsinduced
intestinal inflammation.
Intriguingly, SLs structurally mimic human endogenous sphingolipids (SPs), with the latter known to mediate
inflammation. In addition, a genus of gut microbiota, bacteroides, also produces SPs but not SLs. The bacteroidesderived
SPs were recently shown to enter hosts’ metabolism and are critical for maintaining intestinal homeostasis
and symbiosis. Taken together, this raises an interesting hypothesis that SLs may directly induce
inflammation, but also may modulate inflammation by affecting intestinal homeostasis of SLs and SPs.
Thus, we are now set up to unambiguously establish, both in vitro and in vivo, the role of SLs in mediating HFDsinduced
intestinal inflammation, with an emphasis on the potential relationship between SLs and SPs. This goal
will be achieved through completion of the following Specific Aims (SA).
SA 1: Characterizing the HFDs-associated expression of microbial SLs, microbial SPs and host endogenous SPs.
SA 2: Investigate the activities and relationship of SLs and SPs in mediating intestinal inflammation, using both invitro
assays and in vivo germ-free mouse models. in vitro and in vivo, the role of SLs in mediating HFDs-induced intestinal
inflammation, with an emphasis on the potential relationship between SLs and SPs. This goal will be achieved
through completion of the following Specific Aims (SA).